Molecular pathogenesis of COVID-19-associated coagulopathy and new therapeutic approaches

Project Summary
Many studies have highlighted a large incidence of hemostatic derangements in the form of hypercoagulable
and hypofibrinolytic states following SARS-CoV-2 infection. These hemostatic disturbances are fueled by and a
consequence of the concomitant activation of the endothelium following a severe inflammatory response, with
likely contribution from many other pathways and components, such as the complement pathway and neutrophil
activation. In COVID-19 patients, the resulting hyperinflammation, vascular dysfunction, and systemic
hypercoagulability, collectively referred to as COVID-19-associated coagulopathy (CAC), manifests as the
increased tendency of micro-thrombosis of different organs leading to organ dysfunction, venous
thromboembolism, pulmonary embolism, and deep vein thrombosis. Reducing the deleterious impact of CAC
during severe SARS-CoV-2 infections continues to represent a major therapeutic challenge. Despite the
enormous effort exerted during the pandemic to understand the pathological mechanisms responsible for the
severity of SARS-CoV-2 infections, a major knowledge gap about the drivers and mechanisms underlying CAC
still exists. Furthermore, as the link between CAC and long COVID becomes more apparent, understanding CAC
is more urgent than ever. Proposed studies are designed to gain knowledge on the drivers and mechanisms
underlying CAC and will test the feasibility of several potential pharmacological approaches to blunt it. Levering
our novel and carefully optimized mouse model of COVID-19 and CAC, relying on a human pathological SARS-
CoV-2 strain and recapitulating major pathological alterations and development of CAC observed in human
patients presents a unique opportunity for hypotheses-driven research in a controlled and systematic manner to
gain important new insights on CAC. Mimicking worldwide observations that males are more susceptible to
severe disease after SARS-CoV-2 infection compared to females, a sex-dependent bias in disease severity was
also observed in our model that was accompanied by striking temporal, quantitative, and qualitative differences
in the development of CAC. Aim 1 will characterize the major molecular determinants of the sex-biased disease
severity and development of CAC in our mouse model of COVID-19 and CAC. Key questions that will be
addressed are the extent to which the sex bias originates from hormonal differences, whether estrogens are
protective and/or androgens are deleterious, and whether hormonal supplementation therapy can alter the
development of CAC. These studies will help identify novel pathways and targets for CAC. Aim 2 will expand on
our preliminary data to characterize von Willebrand Factor (VWF)’s function(s) and protein/protein interaction(s)
that are responsible for modulating survival during SARS-CoV-2 infection and development of CAC. The results
of these studies will increase our knowledge of the mechanisms involved in regulating the finely tuned interaction
between the immune, endothelial, and coagulation systems upon SARS-CoV-2 infection, possibly leading to the
identification of new therapeutical targets for the treatment of CAC.

Public health relevance
Project Narrative SARS-CoV-2 is the virus responsible for the severe respiratory disease named as coronavirus disease 19 (COVID-19), which has been declared a pandemic in March, 2020. While susceptibility to COVID-19 infection doesn't show any sex specificity, clinical outcomes show that males experience both a higher severity and mortality upon SARS-CoV-2 infection compared to females. Here we describe a COVID-19 mouse model mirroring pathological alterations in coagulation, endothelial activation, and platelet function associated with the human infection, allowing in vivo studies to explore the molecular mechanisms responsible for the sex-specific difference in severity driving the coagulopathy associated with the infection and new therapeutic options for the treatment of severe viral infections.